CPMV-Polymer Devices to Enhance the Outcomes of Intratumoral Immunotherapy

CPMV-Polymer Devices to Enhance the Outcomes of Intratumoral Immunotherapy
Steinmetz (PI) and her colleagues have developed a plant virus nanoparticle immunotherapy that
activates innate immune cells in the tumor microenvironment (TME) to launch adaptive, systemic, and
durable antitumor immunity. Specifically, we found that nanoparticles based on cowpea mosaic virus
(CPMV) stimulate a potent antitumor response in solid tumor mouse models and in canine cancer patients.
Intratumoral immunotherapy CPMV overcomes immunosuppression within the TME launching adaptive
antitumor immunity and immunological memory to prevent cancer recurrence. CPMV interacts with the immune
system in a multivalent manner, resulting in a cascade of events boosted by avidity to achieve unprecedented
potency. The intratumoral immunotherapy development pipeline is advancing quickly, but its
effectiveness faces challenges, necessitating better delivery methods. Key issues include: (1) Large
tumors often need more drugs or multiple injections, complicating procedures and possibly affecting therapy
results due to variability. (2) High fluid pressure in tumors, caused by factors like vascular issues and confined
cell growth, can impede drug delivery and even push drugs out of the tumor. (3) Frequent dosing can
discomfort patients (and/or owner’s when patients are dogs), affecting their willingness to continue treatment.
Therefore, we propose slow-release CPMV-polymer blend formulations for delivery as injectable
devices. CPMV will be incorporated into polymer blends by applying scalable hot melt extrusion (HME)
processing technology. Pokorski (MPI) is an expert in HME processing of biologics and our preliminary data
confirm the structural and biological stability of CPMV released from the device technology. Finally,
protein/polymer melts will be converted into injectable implants and microparticles using routinely available
milling and molding equipment. We will fulfill the following aims: First, we will formulate CPMV-laden slow-
release devices, establish and tune the release rates, confirm the structural integrity and biological activity
released CPMV from the delivery technology. Second, we will perform clinical testing to establish efficacy,
mechanism of action, and safety as a function of dose and delivery device. While the approach and CPMV
intratumoral immunotherapy is tumor-agnostic, we will focus on metastatic breast cancer. To mimic a patient
population with different subtypes of breast cancer, we will use immune-competent mouse models of
metastatic disease including models of triple negative breast cancer, HER2+ and ER+/HER2- tumors. Third, as
a prelude toward translation, we will perform a phase 0 canine trial enrolling canine patients with non-
metastatic and metastatic mammary tumors; in collaboration with Co-I Peña. Companion dogs with
spontaneous tumors provide a uniquely powerful resource that can be used for translational research as well
as treatment of someone’s well-loved pet.

Public health relevance
Narrative Our team has created a plant virus nanotechnology that, when injected into tumors, alters the tumor environment to boost immune responses against the tumor - this method has shown effectiveness in mouse tumor models and canine cancer patients. However, challenges like large tumors needing multiple injections and high fluid pressure in tumors can limit its success. This grant aims to design slow-release polymer blends as injectables, to simplify the procedure and reduce repeat doses. Effectiveness will be evaluated in mice and dogs.